WEIGHT GAIN ON PSYCHOTROPIC MEDICINES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to identify medications and risk factors associated with weight gain, which will be used to gather data for future prospective intervention and prevention trials.